Radiation Oncology Branch - Radiation Clinic

ROB has had a productive year publishing manuscripts related to clinical care. We have several manuscripts focused on prostate treatment. Many of big data models and patients with gliomas. And several as part of national working groups to help define the standard of care for several diseases. This year we will continue to focus on prostate and GBM but new trials for patients with heme malignancies and adrenocortical cancers are starting. There has been much turnover in multiple clinics and branches which has made clinical care more difficult. Luckily, ROB has been stable thus far.